Core B: Data Management

PROJECT SUMMARY – CORE B: DATA MANAGEMENT
The Data Management Core will create, operate, and maintain state-of-the-art computer systems to store and
safeguard the diverse types of data generated by our Center, and develop protocols and interfaces to share
those data between the institutions in our Center as well as with the ReVAMPP Coordination and Data Sharing
Center (CDSC). We will collate and collect information from all institutions in the Center, including in silico
computational results, high-throughput sequencing data, and experimental data. Our main in silico data are
design models of new proteins, comprising models of the designed protein structures, their amino acid
sequences, and associated scores and metrics. Experimental data include negative-stain and cryo electron
microscopy images; x-ray diffraction images; atomic coordinates of determined protein structures;
deep-sequencing reads and their interpretation; and various wet lab assay results in spreadsheets-like formats.
We will follow the industry-standard and NIH-mandated security practices to manage access to the systems we
operate and all data backups, and the NIH FAIR data sharing principles to annotate newly generated data and
make it available to others. We will distribute our computational methods as free open-source software on
GitHub to make our analyses reproducible and accelerate biological research worldwide. Furthermore, we will
expand and maintain our on-site high-performance computing resources to add storage capacity for the data
we generate and computational capacity for data processing. In addition, we will manage user access to those
resources and provide training on best-use practices of the resources operated by this Core.